Phase 1a/1b Clinical Trials of Multivalent Opioid Vaccine Components

Project Summary
Currently, abuse of prescription opioid analgesics and heroin is a pervasive problem in the U.S. Although
several medications, including methadone, buprenorphine, and naltrexone, are available and effective in
treating opioid use disorder (OUD), long-term relapse rates remain high. The current studies are designed to
examine a novel approach to treating OUD, namely use of a vaccine (OXY-KLH) targeted against oxycodone,
one of the most commonly abused prescription opioids, and a vaccine (M-KLH) targeted against
heroin/morphine. Ultimately, a bivalent vaccine (OXY-KLH and M-KLH) will be developed that will target
oxycodone and heroin. The long-term goal of this research is to develop a multivalent vaccine directed against
oxycodone, heroin, and other relevant opioids. However, during our pre-IND meeting, the FDA/CBER asked
that we study each vaccine separately before moving forward with development of the bivalent vaccine. The
current application proposes a Phase 1a/1b study designed to evaluate the safety (Aim 1), immunogenicity
(Aim 2), and preliminary efficacy (Aim 3) of OXY-KLH during the UG3 phase of the grant period (Study 1) and
a similar Phase 1a/1b study of M-KLH during the UH3 phase of the grant period (Study 2). Transition to the
UH3 phase will be determined after safety, immunogenicity, and preliminary efficacy analyses have been
performed for the OXY-KLH vaccine. Overall, the proposed studies will provide a great deal of information
about the safety and potential efficacy of the vaccines in reducing the abuse liability of opioids, which will be
administered in a controlled laboratory setting. If the outcomes of the proposed studies with OXY-KLH and M-
KLH are favorable, we will proceed with development of the bivalent vaccine (OXY-KLH plus M-KLH).

Public health relevance
Opioid use disorder (OUD) is a serious public health problem that is associated with high rates of morbidity and mortality. The proposed Phase 1a/1b studies are designed to evaluate a novel treatment strategy for OUD. Specifically, the safety, immunogenicity and preliminary efficacy of a vaccine (OXY-KLH) targeted against oxycodone (Study 1) and a vaccine (M-KLH) targeted against heroin/morphine (Study 2) will be evaluated in participants diagnosed with OUD.